Support to provide travel awards for the 2017 ASN Advances in Research Conference

PROJECT DESCRIPTION The annual meeting of the American Society of Nephrology (ASN) is the largest gathering in the world of clinical and basic scientists working on the kidney. During the first two days of Kidney Week, the ASN sponsors a series of intensive symposia including a two-day Advances in Research Conference (ARC) for clinician investigators, graduate students, postdoctoral fellows, early- to mid-career academicians, practicing physicians and allied health care professionals. The subject area of this symposium is reviewed thoroughly by the ASN's Continuous Professional Development Committee and Program Committee, and reflects important and time- sensitive areas of clinical and translational investigation with important clinical and public health implications for the management of kidney diseases and their related comorbidities and complications. The 2017 ASN Advances in Research Conference entitled “Precision Medicine in Renal Disease” is scheduled for October 31-November 1, 2017 at the Morial Convention Center in New Orleans, LA. The conference will explore how advances in molecular and clinical medicine are allowing more comprehensive, molecular-based disease classifications that lead towards targeted therapy development and testing for subpopulations. The purpose of this grant application is to request funds to be issued as travel support awards for trainees, including medical students, graduate students, residents, and fellows, to attend the 2017 Advances in Research Conference. The travel support awards include an $800 stipend and complimentary registration to the early program. These awards provide vital monetary support and help to expose participants to cutting- edge research early in their careers.

Public health relevance
PROJECT NARRATIVE The Advances in Research Conference: Precision Medicine in Renal Diseases will explore how advances in molecular and clinical medicine are allowing more comprehensive, molecular-based disease classifications to define the mechanism of renal damage. This classification will lead towards molecular targeted therapy development and testing in subpopulations with joint underlying disease mechanisms. The course brings together leading scientists, physician-scientists, clinicians, and trainees from diverse areas with common interests in precision medicine and renal diseases.